A causal wiring diagram of transdiagnostic brain functions

Brain imaging has long been criticized for revealing correlations rather than causes. In recent years, there has been a rapid growth of focal brain stimulation technology, which can bring us closer to studying causes. If stimulating a speciﬁc brain circuit causes a speciﬁc behavioral change, then that circuit can be inferred to have a causal role in that behavior. However, the number of potential stimulation sites is practically inﬁnite. This makes it diﬃcult to test the causal relevance of every possible stimulation target and every possible behavior. There is a need for a systematic wiring diagram that narrows the ﬁeld of potential options, enabling researchers and clinicians to make informed decisions about stimulation targets. In this proposal, we will develop this wiring diagram. Using highly-sampled resting-state functional MRI scans as well as cutting-edge brain stimulation protocols, we will randomly apply stimulation to diﬀerent targets in each participant. To address the problem of a near-inﬁnite target space, we will narrow it down by mapping whole-brain connectivity of each target, not just its location. As a result, we will have information about every brain region for every participant, enabling us to draw whole-brain-level contrasts. Using this information, we will map the circuitry connected to TMS sites that modulate a wide range of diﬀerent behaviors relevant to mental illness, including transdiagnostic behaviors and diagnosis-speciﬁc symptoms. We will include patients with major depression, obsessive- compulsive disorder, schizophrenia, and generalized anxiety disorder. If successful, the study will yield a multidimensional atlas of causal brain circuitry, which can be used by future researchers and clinicians to select a stimulation target that is appropriate for the a speciﬁc patient based on their symptoms and objective emotional testing.

Public health relevance
The goal of this study is to identify new brain circuits that are causally involved in symptoms of mental illness. These circuits can then be used as treatment targets for brain stimulation, a technique that can be used as a treatment for various mental illnesses.